Initiation of immune responses to SARS COV2 in the oral cavity and upper airway

Abstract
Infection with severe acute respiratory syndrome coronavirus 2 (SARS-CoV-2) causes coronavirus disease 2019
(COVID-19), a life-threatening illness with multi-system involvement in a subset of infected individuals. Oral and
nasopharyngeal (NP) epithelial cells express the SARS-CoV-2 receptor ACE2, and infection of the
oral/nasopharyngeal cavity (ONP) is likely an obligate step in the development of COVID-19. Immune responses
first generated in the ONP are almost certainly crucial for viral clearance but may also play a central role in the
development of hyperinflammatory injury observed in many infected individuals. We have used single cell (sc)-
RNA sequencing from a racially diverse prospective cohort of COVID-19 patients to identify distinct subsets of
ciliated epithelial cells within the NP that are direct targets for SARS-CoV-2 infection and have described innate
anti-viral responses generated by those cells within both directly infected as well as non-infected bystander cells.
Interestingly this analysis demonstrates that increased mortality is linked to blunted anti-viral gene response in
the NP, suggesting that a successful innate response to viral infection in the nose is a critical component of a
successful anti-viral response. In addition to the nose, there is strong evidence that SARS-CoV-2 can infect the
oral epithelium. While there are several anatomic sites within the mouth that are likely involved in anti-viral
responses, the gingival sulcus is a unique immunologically active location that is crucial for maintaining oral
health. The gingival epithelium expresses both the SARS-CoV-2 receptor ACE2 as well as the host protease
TMPRSS2 necessary for viral entry, but exhibits important immunological differences compared to the nasal
epithelium including a bias towards IL-17 associated neutrophil responses. Thus, our overall hypothesis is that
identifying and enhancing successful innate and adaptive cellular immune responses of the nasal and gingival
epithelium will lead to novel therapeutic avenues for COVID-19. To address this hypothesis, propose the
following aims: 1. Stratify cell states and viral dynamics across mucosal surfaces following SARS-CoV-2
infection and vaccination; 2. Compare memory T cell responses within the nose and gingiva that are associated
with successful or pathogenic responses to SARS-CoV-2; and 3. Characterize the regulation of host innate
immune defense mechanisms that are essential to limit propagation of SARS-CoV-2 infection within ONP
epithelial cells. To accomplish these aims, we will analyze human ONP samples from individuals with COVID-
19, recovered from COVID-19, and vaccinated for COVID-19 using sc-RNA-seq, flow cytometry, and other
molecular biology techniques. At completion, the project will define the protective innate and adaptive immune
mechanisms operating in the ONP of patients infected with SARS-CoV-2, improve our overall understanding of
viral induced immunity in the ONP, and provide insight into how these pathways influence disease pathogenesis.

Public health relevance
Narrative SARS COV2 infection leads to significant morbidity and mortality. The major point of entry for the viral infection is the mouth and nose but little is known about how the immune cells in these areas interact with and responds to SARS COV. Improving understanding of which cells are affected and how the virus triggers inflammatory response in them is critical for SARS COV2 management and treatment.